Novel Statewide Response to Post-COVID Care Delivery

PROJECT SUMMARY
Long COVID is an important public health threat impacting millions of individuals including 600,000
Coloradans. Current Long COVID care is highly fragmented, variable in nature, and in constant evolution.
Creating a novel approach to practice support with continued education and streamlining care for high Long
COVID will improve care integration and patient experience. We will implement the Colorado Multidisciplinary
Translation Network (CO-MTN) comprised of integrated, multidisciplinary Long COVID care clinics and primary
care clinics working together in a tiered care delivery pathway. CO-MTN creates a bidirectional translational
care network for integrating expertise, education, referrals, and care between MDCs, PCPs and teams, and
their patients. CO-MTN includes 1) the State of Colorado-supported Long COVID Community of Practice
comprised of three geographically distributed MDCs, 2) a state-wide practice-based research network
representing 280 primary care practices, known as the State Networks of Colorado Ambulatory Practices &
Partners, and 3) a proven tele-education system used to provide health care practitioners specialty training,
Extension for Community Healthcare Outcomes. CO-MTN includes implementation strategies to support the
tiered care pathway including training and learning communities to support PCPs with improved knowledge
and capacity and provide exceptional care for Colorado Long COVID patients, and practice facilitation to
effectively implement the PCP care in their practice and coordinate with the MDCs. CO-MTN will help Long
COVID patients in Colorado and have the potential for scaling to other states. To guide implementation and
evaluation, we will utilize the Exploration, Preparation, Implementation and Sustainment dissemination and
implementation framework. We will measure sustainment as continued involvement in the network during the
final six months of the project period. Using qualitative, quantitative, and mixed methods, we will evaluate the
Reach and Effectiveness for patients, and the Adoption, Implementation and Maintenance of the
implementation strategies using the RE-AIM framework based on the following aims: Aim 1: Implement an
integrated, tiered care delivery pathway with facilitated implementation support via CO-MTN and measure its
effect on 1) Reach of Long COVID care to Colorado patients, specifically those described as underserved, and
2) Effectiveness on reducing Long COVID symptom burden and severity for patients engaged. Aim 2:
Determine the effect of CO-MTN on 1) Adoption of the CO-MTN tiered care delivery model by primary care
clinics and PCPs within these clinics, 2) Implementation of the tiered care pathway, and 3) Maintenance of the
tiered care pathway key components past the active project period. Our team is comprised of national experts
in Long COIVD care, practice-based research, and implementation science. Together, our multidisciplinary
team will partner through CO-MTN structures and support to deliver high quality Long COVID care.

Public health relevance
PROJECT NARRATIVE: This project will create an integrated care network for Long COVID across the state of Colorado and implement a tiered-care delivery model bridging multidisciplinary and primary care for patients with Long COVID. The study will evaluate the impact of this care delivery model on Long COVID symptom burden and access to care.